Development of an Antiviral to Combat Viral Infections

To support the advanced development of candidate therapeutics for various viral pathogens, including coronavirus and yellow fever, covered under the Antiviral Program for Pandemics. The supported research and development activities will progress the therapeutic product development and may include lead optimization, candidate selection, preclinical and IND enabling studies, Chemistry, Manufacturing, and Controls (CMC), IND submission, clinical safety and efficacy assessment.